Neoantigen immunotherapy in brain tumors using anti-CD27 to deplete regulatory T cells selectively

ABSTRACT – Project 1
In brain tumors like glioblastoma (GBM), failures to develop an effective vaccine and achieve immune
checkpoint inhibition have been attributed to both the remarkable immunosuppression and extraordinary
antigenic intratumoral heterogeneity. A major contributor to immunosuppression in GBM is elevated regulatory
T-cells (TRegs) which dramatically suppress T cell effector function and diminish the efficacy of antitumor
vaccination. Efforts to deplete TRegs by targeting the interleukin-2 receptor α (CD25) have been unsuccessful to
date, due to cytotoxic effects on effector T cells, which are required to promote antitumor immunity. To
overcome this hurdle, Project 1 builds novel preliminary data demonstrating the ability of a clinically available
CD27 agonist antibody (αCD27) to simultaneously deplete TRegs and enhance vaccine-induced immune
responses. Specifically, the Project tests the hypothesis that class I neoantigens linked to universal class II
epitopes will be well-tolerated and rendered more immunogenic by the ability of the clinically available CD27
agonist antibody to deplete TRegs and simultaneously enhance vaccine-induced immune responses in patients
with GBM. Aim 1 will evaluate the safety and therapeutic potential of a neoantigen and Cytomegalovirus
antigen vaccine in combination with dose-escalating αCD27 in patients with GBM. Cumulative results will
provide critical data on the feasibility and immunogenicity of neoantigen vaccination in patients with GBM to
determine if a larger trial is warranted. Aim 2 will determine if αCD27 simultaneously depletes TRegs and
increases vaccine-induced immune responses. It is expected that αCD27 will reduce TRegs in this patient
population while improving vaccine-induced CD8+ and CD4+ T cell responses. If successful, this work will
develop a therapeutic strategy for patients with GBM that has enhanced efficacy by addressing the issues of
host immunosuppression and intratumoral heterogeneity.

Public health relevance
PROJECT NARRATIVE – Project 1 Glioblastoma (GBM) remains uniformly lethal with an overall survival of <21 months despite surgery, high-dose radiation, dose-limited chemotherapy, and novel therapies like tumor-treating fields. Immunotherapy induces remarkable efficacy in many cancers, but its effectiveness in GBM has been limited due to patients' remarkable immunosuppression and extraordinary tumor heterogeneity. This project develops a novel immunotherapeutic platform to address both of these critical issues.